A Phase 2 Study of the Value of Pre-symptomatic Genetic Risk Assessment for Age-Related Macular Degeneration

Project Summary/Abstract
In the past two decades, we have learned that variants in CFH, ARMS2/HTRA1 and other genetic loci are
major risk factors for age-related macular degeneration (AMD) and that nutritional supplementation with
AREDS2 antioxidant vitamins, minerals, and carotenoids could slow the progression of this blinding disorder.
Despite recommendations by the American Academy Ophthalmology (AAO) against routine genetic testing for
AMD risk, many members of the public express an interest in pursuing such testing, and direct-to-consumer
laboratories already market them commercially. The AAO's expert panel did not assert that these tests do not
accurately reflect eventual risk of visual loss from AMD, but rather that there is no proof that knowledge of
AMD risk has any quantifiable impact on behavior that could mitigate the incidence of AMD in their senior
years. A prospective study to show that knowledge of AMD risk could decrease incidence of AMD decades
later would settle this controversy and would be consistent with research recommendations of the AAO expert
panel, but it is not currently feasible due to the large number of subjects and prolonged time required. Instead,
we propose a shorter, Phase 2 randomized clinical trial to study if quantifiable biomarkers of healthy behavior
(skin and ocular carotenoid levels) improve in response to knowledge of AMD risk. We hypothesize that
individuals who are informed of a high risk of eventual AMD will be more likely to make sustained changes in
behavior associated with decreased incidence of AMD later in life such as smoking cessation, weight loss,
decreased light exposure, and diets rich in carotenoids relative to subjects who have deferred testing or who
are informed of low risk. These lifestyle changes will then result in improved levels of lutein, zeaxanthin, and
other carotenoids measured in the skin at one year by resonance Raman spectroscopy (RRS) and reflectance
spectroscopy (RS) and by autofluorescence imaging (AFI) and fluorescence lifetime imaging ophthalmoscopy
(FLIO) in the eye. We will conduct a randomized, controlled clinical trial of immediate versus deferred
disclosure of AMD risk in a 3:1 ratio in up to 80 normal individuals age 18 to 64. Systemic and ocular
carotenoid status will be assessed objectively by skin RRS and RS and by ocular AFI and FLIO. We expect
that subjects informed of high risk of AMD will be more likely to initiate and sustain positive lifestyle changes
that will raise their skin and ocular carotenoid scores significantly at their one-year study visit. We will also
determine correlations between AMD genetic risk with baseline ocular and systemic carotenoid status using
current and newer methods of imaging.

Public health relevance
Project Narrative This Phase 2 study is designed to test whether pre-symptomatic testing for AMD risk can lead to quantifiable long-term changes in behavior and lifestyle that could lead to lower incidence of AMD later in life. Positive results will have major public health impact and would lead to increased utilization of genetic testing to identify individuals at highest genetic risk of AMD so that they can initiate changes long before signs and symptoms appear. Negative results would provide additional support to continue the American Academy of Ophthalmology's current recommendation against pre-symptomatic testing for AMD genetic risk.